Type 2 Diabetes and Bone Health in Youth

Project Summary
Type 2 diabetes (T2D) is associated with lower bone quality and increased risk of fracture in adults. However, it
is not known if early onset T2D has adverse effects on bone accrual and strength. The mean age of diagnosis
of youth onset T2D is in mid-adolescence, likely influenced by pubertal insulin resistance in obese youth at risk
for the disease. Given that bone mineral accrual is occurring in the adolescent years, it is important to understand
whether early onset diabetes may be interfering with adequate bone mineral accrual, and the determining factors.
It is imperative to address this knowledge gap so that we can institute interventions to prevent and reverse the
underlying risk factors, particularly that adverse bone health in childhood may translate to increased risk for
osteoporosis and fractures in adult life. The overarching goal of this proposal is to improve bone health in
children. The central objective of this application is to determine the effect of youth onset T2D on bone accrual,
microstructure and strength, and to understand the factors that may lead to bone fragility in these youth. We
hypothesize that hyperglycemia in youth with T2D has a negative effect on bone formation and is associated
with low bone turnover, altered bone accrual and microarchitecture.
To test this hypothesis, we propose to evaluate volumetric bone mineral density, microarchitecture and strength
by finite-element derived parameters (failure load and stiffness) using high resolution peripheral quantitative
computed tomography (HRpQCT), and bone turnover markers longitudinally in youth with T2D compared with
equally obese youth with normoglycemia and normal weight controls. We will also measure bone mineral content
(BMC) and areal bone mineral density (aBMD) using dual energy X-ray absorptiometry (DXA). We will combine
these evaluations with careful metabolic phenotyping of body composition by DXA, insulin sensitivity and
glycemia (oral glucose tolerance test, HbA1c) and gut hormones that may mediate the effect of diabetes on
bone. We will account for the important modulators of bone health including race-ethnicity, sex, pubertal stage,
physical activity (by accelerometry), and nutrition status.
The study is innovative in elucidating the effects of hyperglycemia on bone accrual and microstructure
longitudinally in the adolescent years using HRpQCT, while carefully considering diabetes related factors
(diabetes duration, treatment) and other important covariates. We anticipate that we will establish that
hyperglycemia in youth with T2D has an adverse impact on bone turnover resulting in lower bone accrual and
strength in youth with T2D compared with equally obese youth with normoglycemia and normal weight controls.
Our data from this R21 pilot and feasibility experimental study will pave the way for 1) studying lifestyle
interventions that target glycemia to improve bone accretion in adolescence, and 2) evaluation the effects of
pharmacotherapy on bone health in youth with diabetes to best inform clinical management of these youth.

Public health relevance
Project Narrative The proposed research is relevant to public health in addressing an important research gap in our understanding of the adverse effects of type 2 diabetes on bone health in childhood that may translate to high risk for bone fragility and bone fractures in adulthood. The project aligns with the NICHD's research priority in identifying the processes contributing to acquisition of bone mass and strength throughout childhood, and studies leading to the identification of risk factors for bone fragility especially in children with chronic illness. The findings from this study will help design future studies aiming at interventions that protect bone health in youth.